Exa-scale tissue readout methods

PROJECT ABSTRACT
Our brain is the most complex system under study. It relies on precise wiring and signaling across billions of
neurons. Our neurons span centimeters, communicating with one another via a sea of sub-micrometer synapses
and nanoscale proteins. At the same time, each of our neurons has a distinct type, stemming from its unique
expression of thousands of genes, and can assemble into spatial gradients with other neurons that span entire
regions of our brain. Charting vast multi-dimensional maps of our brain is one of the greatest challenges of
modern neuroscience, with far-reaching implications for shedding light on the mechanisms of brain function and
improving our ability to diagnose and treat neurological diseases. However, the size and scale of these maps is
unprecedented, as they require us to see the big (i.e., the entire brain) and the small (i.e., individual synapses,
proteins, and RNA transcripts) in a highly multiplexed manner (i.e., many molecular markers). A growing number
of recent innovations in tissue processing, including tissue expansion for microscopy (physically enlarging
tissue), multiplexed antibody labeling (protein mapping), and in situ sequencing (reading out mRNA in tissue
using sequencing by synthesis), now make it possible to visualize hundreds of molecular entities in three
dimensions across centimeter-scale tissue volumes at resolutions that exceed the diffraction limit. At the same
time, the cost of data storage and computation continues to decrease according to Moore’s law. These
breakthroughs open the door to a new frontier of scientific discovery that is not bounded by our ability to
interrogate the molecular contents of tissue, or store and process the resulting imaging data. This frontier is
instead severely bounded by our current imaging technologies and the rate at which we can collect high-
resolution, highly multiplexed data from large tissue volumes. Here I propose to develop a pair of Exa-scale
Tissue Readout Methods (ExTReMe) that overcome this boundary and improve imaging throughput by orders
of magnitude over current state-of-the-art approaches. I will develop a first ExTReMe platform to enable a new
type of molecular interrogation of neural circuits, mapping individual proteins at molecular resolutions, in a highly
multiplexed manner, across entire brains. I will develop a second ExTReMe platform to scale in situ sequencing
methods to larger mammalian brains. Mapping neuron types across the macaque or human brain will be
accomplished in several months or years, as opposed to several decades or centuries. These new imaging tools
will transform our understanding of the brain’s cell types and their connections and provide detailed molecular
fingerprints of neurological and neuropsychiatric disorders. Although this project focuses on applications in brain
research, both ExTReMe platforms will have broad impact in other fields, including but not limited to oncology,
immunology, and developmental biology.

Public health relevance
PROJECT NARRATIVE The field of spatial biology is transforming the landscape of scientific discovery, improving our ability to probe the mechanisms that underly disease states and the response of diseased cells and tissues to treatments. It is critical to extend these methods to bigger and bolder scientific questions, yet we currently lack imaging tools that are fast and efficient enough to support the scale that these experiments will demand. To address this need, this project will develop a pair of Exa-scale Tissue Readout Methods (ExTReMe).